Diabetic Complications and Genetic Variants in the Million Veterans Program

We propose to undertake analyses within the Million Veterans Program (MVP)
database to Assess Associations between Diabetic Complications and Genetic
Variants. Aim 1 involves Database Development that will create a virtual baseline
examination linking MVP data to VAMC outpatient visits, and, when appropriate, VAMC
hospitalizations, using the electronic health record. We will conduct cutting edge
Genome Wide Association Studies (GWAS) of common (CVAS) and rare (RVAS)
variants. The outcomes investigated are diabetic eye, kidney, and cardiovascular
complications, and hypoglycemia. Aim 2 is Diabetes Complications Analyses
concerning outcome risks using time-integrated longitudinal measures of risk factors
(RFs) to include both genetic variants and traditional RFs considering both single and
multiple assessments of outcomes with cross-sectional and period prevalence
estimates. We will analyze organ-specific and metabolic complications according to type
1 and type 2 diabetes status using EHR data in VA records. Specific outcomes
investigated: Ocular (retinal disease, glaucoma), Renal (micro- and macro-albuminuria,
and decreased eGFR [CKD stages and ESRD), Cardiovascular (cardiac failure), and
Hypoglycemia (emergency department visits and hospitalizations, adjusted for HbA1c
and glucose levels, and use of glycemic medications [from the EHR]). Aim 3 will
develop Diabetic Complications Risk Scores. Both traditional RF and separate
genetic prediction models will be compared using logistic regression for each outcome.
Models will evaluate the role of RFs and pharmacologic therapy for abnormal blood
pressure, lipids, and glucose. We will use an outcome-specific genetic score as a
potential reclassification variable.

Public health relevance
We propose to undertake analyses to assess “Diabetic Complications and Genetic Variants in the Million Veterans Program.” Aim 1 involves Database Development to create a virtual baseline within the Million Veterans Program (MVP) database, linking MVP data to the VAMC electronic health record (EHR). Aim 2 is Diabetes Complications Analyses concerning outcome risks according to diabetes status using VA EHR data: Ocular (retinal disease, glaucoma), Renal (micro- and macro- albuminuria, and decreased eGFR [CKD stages and ESRD), Cardiovascular (cardiac failure), and Hypoglycemia (emergency department visits and hospitalizations). Aim 3 will develop Diabetic Complications Risk Scores using traditional and genetic RF information.